Controlling Neuropilin-2 Signaling to Improve Lymphatic Function

Lymphatics are vital for fluid recycling, immune surveillance, and lipid uptake. Abnormal lymphatics lead to
lymphedema, metabolic changes, inflammation, and infections and contribute to the pathophysiology of many
chronic illnesses. In response to the NIH mission (NOT-HL-23-099) promoting research on the biology of the
lymphatic system to advance discovery of novel drugs for lymphatic diseases, we have identified Neuropilin-2
(NRP2) as a pivotal manipulator of lymphatic function. NRP2 is a unique transmembrane receptor in lymphatic
endothelial cells (LEC) capable of signaling through disparate and opposing ligands. Our central hypothesis is
that NRP2 acts as a dynamic rheostat by toggling between its ligands and downstream signaling pathways to
either promote or restrain fluid and lipid uptake into lymphatic vessels. Using innovative biochemical, genomic,
and pharmaceutical strategies in new animal models, we will test our hypothesis by defining, modulating, and
controlling NRP2 ligand-dependent signaling in lymphatics. NRP2 binds VEGFC in complex with VEGFR3 to
increase lymphatic function. Our compelling new data reveals that NRP2 is necessary for VEGFC-induced
activation of VEGFR3, adult lymphangiogenesis, and proper lymphatic drainage functions in vivo. On the other
hand, the inimitable NRP2 receptor can also bind SEMA3F in complex with PlexinA1 to inhibit lymphatic functions
such as absorption and immune cell trafficking. In Aim 1, we will alter Nrp2 expression and ligand-dependent
functions in the skin to sustain proper fluid drainage and ameliorate lymphedema. In preliminary studies,
systemic neutralization of the endogenous Sema3F ligand in adult wildtype mice increases VEGFC binding to
NRP2 and accelerates lymphangiogenesis following injury to restore lymphatic drainage and alleviate secondary
lymphedema. However, increasing lymphatic drainage is not always advantageous. In the GI tract, specific
lymphatic capillaries called lacteals facilitate lipid absorption. In Aim 2, we will temper Nrp2 expression and
ligand-dependent functions in the intestine to block lipid influx and prevent diet-induced obesity. To date, the role
of NRP2 in lacteal function, lipid absorption, or lipid transport has not been investigated, especially in relation to
adult weight gain or digestive inflammatory disease. In accordance, global or conditional Nrp2 loss in lacteals
correlates with lower basal body weight and reduced weight gain with high fat diet compared to controls.
Specifically, we will establish the therapeutic potential of inhibiting differential ligand-binding domains in Nrp2
using systemic antibodies or exogenous competitive proteins in preclinical models to either promote
VEGFC/NRP2 signaling to alleviate lymphedema or to limit VEGFC/NRP2 signaling in lacteals to hinder lipid
absorption to prevent obesity or metabolic disease. Overall, our proposal is significant and warrants careful
consideration as it will reveal distinct lymphatic regulatory mechanisms and use inventive approaches to curtail
lymphedema or obesity and their comorbidities. Since humanized versions of these drugs already exist, our
results may quickly translate into viable and effective treatments to improve lymphatic diseases.

Public health relevance
PROJECT NARRATIVE The current application is directly relevant to the mission of the NIH pertaining to fostering discoveries and innovative research strategies as it uncovers a novel receptor signaling axis capable of controlling lymphatic capillary junctions to manipulate the influx of fluids or exclusion of dietary lipids. Completion of the proposed research project will reveal new pathways governing the lymphatic vascular system and innovative pharmaceutical modalities to modulate lymphatic drainage, prevent weight gain, enhance immune function, and improve overall health.